Virtual Hope Box Enhanced Facilitation in High-Risk Suicidal Veterans

Background: Veteran suicide rates are 1.5 times higher than the general population rates and are especially
high following discharge from an inpatient mental health unit when up to a third of patients do not receive
timely outpatient follow-up care. Technology-based interventions are a scalable approach to provide additional
support to patients during these high-risk transitions. The Virtual Hope Box (VHB), a mobile phone application
(app) developed by the Department of Defense (DoD) and VA, allows patients to access reasons for living and
coping tools regardless of their location. VHB was effective for improving coping self-efficacy in a small
randomized controlled trial; however, no studies have been adequately powered to examine VHB’s
effectiveness for suicide attempts. Additionally, knowledge and use of the app is low according to a preliminary
study of mental health inpatients, calling for new strategies to facilitate greater use and impact of the VHB app.
Significance: The suicide rate among Veterans rose 35.9% from 2001 to 2019, leading to VA to make suicide
prevention a top clinical priority. We developed an intervention, which includes the VHB app and its enhanced
facilitation (VHB-EF), with the aim of reducing Veteran suicide attempts. Developing and implementing
effective strategies to reduce suicide attempts post-hospitalization is also a research priority within this RFA.
Innovation/Impact: We developed VHB-EF to provide awareness, active engagement, and support of VHB
with the aim of reducing suicide attempts post-hospitalization. This study will be the first to test the
effectiveness of VHB-EF on suicide attempts and may improve safety after discharge. It will examine potential
intervention mechanisms, according to self-efficacy theory and the theory of planned behavior, while also
considering ultimate implementation and scalability of the VHB-EF through provider and Veteran feedback.
Specific Aims: Aim 1: Determine the effectiveness of VHB-EF for reducing suicide attempts. Aim 2: Examine
the intervention mechanisms by measuring the effects of VHB-EF on 1) reasons for living, and 2) self-efficacy
to (a) cope and (b) refrain from suicide attempts. Exploratory Sub-aim 2: Examine whether higher reasons for
living and self-efficacy partially mediate the effect of VHB-EF on suicide attempts over 6 months. Aim 3:
Assess the determinants (barriers and facilitators) of VHB-EF adoption to inform future implementation and
sustainability of VHB-EF across the VA.
Methodology: A randomized effectiveness-implementation Hybrid Type I trial will be conducted at two VHA
inpatient mental health units. We will randomize 928 Veterans hospitalized after a suicidal crisis to either VHB-
EF or Enhanced Usual Care (EUC). The VHB-EF includes a single session on the unit that educates Veterans
on app purpose for suicide prevention, loads the app on their personal phone, provides practice of each app
component, and discusses strategies to enhance app usage after hospital discharge. It also includes a remote-
delivery phase which includes 2 phone calls after discharge to monitor risk, review/revise VHB content, and
support app use and outpatient treatment engagement. The EUC arm consists of reviewing a community
resources list. We will assess how VHB-EF (vs. EUC) impacts suicide attempts, as well as potential mediators,
across follow-up assessments (6 weeks and 3- and 6- months post-randomization). Qualitative interviews with
providers and Veterans will focus on barriers and facilitators of adoption.
Next Steps/Implementation: The VHB is already accessible in VA, but active intervention is needed to
engage high-risk suicidal Veterans, and additional effectiveness evidence is needed to support its
incorporation into treatment guidelines for suicide prevention. Through qualitative interviews we will examine
the determinants (barriers and facilitators) of VHB-EF adoption to inform future implementation and
sustainability of this approach across the VA. Broader implementation of the intervention will be coordinated
with Office of Mental Health and Suicide Prevention who supports the proposal.

Public health relevance
In 2014, a DoD/VA collaboration created the Virtual Hope Box (VHB) mobile app to support suicide prevention. Despite years of investment, the VA does not know if the VHB works and over 90% of high-risk Veterans hospitalized with a recent crisis state they have never heard of it (and even fewer have actually used it). Two VA Medical Centers (Ann Arbor and Puget Sound) will conduct a study of the VHB Enhanced Facilitation (VHB-EF) intervention in which a therapist will help educate Veterans on app purpose for suicide prevention, load the app on their personal phone, practice each app component, discuss strategies to enhance app use, and follow-up after hospital discharge to check-in and support VHB use. This study aims to examine the VHB- EF’s effect on suicide attempts using a randomized controlled trial and explore facilitators and barriers for future implementation of the VHB-EF. Stakeholder input from Veterans and providers (qualitative interviews) will be used to evaluate the VHB-EF and will enable the development of a toolkit for others in the VA to use.